Exogenous Modulation of Visual Perception And Connectivity in Body Dysmorphic Disorder (EMPAC-BDD)

PROJECT SUMMARY
Individuals with body dysmorphic disorder (BDD) misperceive aspects of their appearance to be conspicuously
flawed or defective, despite these being unnoticeable or appearing miniscule to others. With convictions of
disfigurement and ugliness, they typically have poor insight or delusional beliefs, obsessive thoughts and
compulsive behaviors, anxiety, and depression. These result in significant difficulties in functioning,
depression, suicide attempts (25%), and psychiatric hospitalization (50%). Despite this, relatively few studies of
the neurobiology, and few treatment studies, have been conducted. This underscores a critical need for
research to identify novel targets for intervention based on a comprehensive understanding of the
pathophysiological mechanisms. Previous research has uncovered mechanisms that may contribute to
perceptual distortions, including prominent abnormalities in visual processing systems. These have contributed
to a model of diminished global/holistic processing and enhanced local/detailed processing, attributed to
“bottom-up” and “top-down” disturbances in perception. Previous experiments using psychophysical tests,
novel behavioral visual modulation techniques, and functional magnetic resonance imaging (fMRI) have
probed the brain’s visual systems responsible for global and local processing and found early evidence that
they may be modifiable in BDD. This study will test if further modification could be achieved using noninvasive
neuromodulation with repetitive transcranial magnetic stimulation (TMS). Such modulation may be necessary
to enhance the effects of behavioral modulation and induce the magnitude of functional changes necessary to
achieve clinically meaningful improvements in perceptual experiences in those with BDD. The proposed
experiment will determine whether excitatory and inhibitory TMS enhances and inhibits, respectively, the
effects of a behavioral visual modulation strategy on brain connectivity and on global visual processing on a
psychophysical task. This will be tested in individuals with clinical BDD and in individuals with subclinical BDD.
Results will contribute to a comprehensive mechanistic model of abnormal visual information processing
underlying the core symptom domain of misperceptions of appearance. Further, results will be critical for the
development and optimization of future combinations of neuromodulation and novel perceptual retraining
treatments.

Public health relevance
PROJECT NARRATIVE There is a critical need for research in body dysmorphic disorder (BDD) to identify targets for intervention based on pathophysiological mechanisms, particularly for perceptual distortions of appearance. Accordingly, this study aims to understand the effects of noninvasive brain stimulation in combination with a behavioral visual modulation technique on brain function and visual perception. This is an important step toward developing new treatment components for BDD.